Microvascular/Endothelial Dysfunction and Postoperative Atrial Fibrillation

Summary
Postoperative atrial fibrillation (POAF) is the most common complication of cardiac surgery in the world, affecting 30-
50% of patients and incurring significant morbidity and mortality with elevated risk for postoperative stroke, heart
failure, and death. Despite extensive research and advancements in antiarrhythmic therapy, the incidence of POAF
remains high and has not changed in decades. Growing evidence indicates that endothelial dysfunction is correlated
with chronic atrial fibrillation (AF). However, the direct relationship between atrial microvascular/endothelial
(dys)function following cardioplegic arrest and cardiopulmonary bypass (CP/CPB) and the development of new onset
of POAF is largely undefined. Moreover, the changes that occur in the atrial microvasculature/endothelium following
CP/CPB and cardiac surgical procedure in patients with POAF are poorly understood. Thus, the goal of this patient-
oriented proposal is to investigate how dysfunction in the cardiovascular physiology of atrial microvasculature and
endothelium affects POAF. Importantly, our preliminary studies indicate that enhanced atrial arteriolar vasomotor tone
and impaired atrial endothelial function following CP/CPB are associated with the new onset of POAF. Furthermore,
atrial microvascular fibrosis in aged patients is significantly corelated with POAF. Therefore, we hypothesize that
atrial microvascular/endothelial dysfunction and altered vascular/endothelial signaling at baseline (pre-CP/CPB) and
pos-CP/CPB contribute to the development of POAF. In Aim 1, we will evaluate microvascular signaling pathways
responsible for myogenic/vasomotor/endothelial dysfunction of the atrial microvasculature in patients with POAF; In
Aim 2, we will investigate cellular/molecular alterations of atrial endocardial endothelial dysfunction in patients with
POAF; In Aim 3, we will analyze the differential genomic expression in vascular smooth muscle cells/pericytes,
endothelial cells, and fibroblasts in the harvested atrial tissue samples pre- and post-CP/CPB from patients with and
without POAF. We will further analyze the impact of age, sex, diabetes, and hypertension on atrial
microvascular/endothelial dysfunction correlated to POAF. To achieve these goals, we will recruit a cohort of 500
cases with and without POAF, along with human atrial tissue samples of both pre- and post-CP/CPB, atrial arterioles,
atrial cardiomyocytes, and endothelial cells from patients with or without POAF. We will employ multiple cutting-edge
approaches, including a human CP/CPB model, microvascular physiology, cardiovascular electrophysiology, and
novel cellular/molecular approaches. This proposal will develop a novel concept that microvascular/endothelial
dysfunction/signaling of atrial microcirculation play important roles in POAF; bring new insights into endocardial
endothelial dysfunction related to POAF by exploring novel cellular/molecular changes of the endocardial endothelium
related to POAF; and identify novel genetic mechanisms of atrial microvascular/endothelial dysfunction related to
POAF. By doing so, this proposed research will provide the basis for the development of new approaches to decrease
the incidence of POAF in patients undergoing cardiac surgery.

Public health relevance
Postoperative atrial fibrillation affects 30-50% of patients and incurs significant morbidity and mortality. The goal of the current project is to investigate the impact of atrial microvascular/endothelial dysfunction on the development of new-onset-of postoperative atrial fibrillation (POAF) in patients following cardiac surgery, and to analyze how various risk factors (aging, sex, diabetes, and hypertension) differentially affect atrial microvascular/endothelial dysfunction related to POAF This study will lead to novel therapies for predicting, preventing and treating POAF in patients following cardiac surgery.